Categorical and dimensional investigations of dynamic functional connectivity and behavior during response inhibition in children with and without ADHD

PROJECT SUMMARY
Attention-deficit/hyperactivity disorder (ADHD) is the most commonly diagnosed neurodevelopmental disorder
of childhood and affects approximately 5-10% of children worldwide. ADHD is characterized by core symptoms
of inattention, hyperactivity, and impulsivity, though there is much heterogeneity in the ADHD phenotype. Much
research into the specific neural dysfunction underlying the pediatric ADHD phenotype has employed categorical
approaches, comparing children with ADHD to typically developing children. However, children with and without
clinical ADHD diagnoses experience a wide range of ADHD-related symptoms. As individuals with ADHD
symptom burden, regardless of diagnosis, are at risk for negative-long term outcomes, the proposed studies will
investigate the ADHD phenotype categorically and dimensionally to increase the understanding of the neural
substrates of ADHD symptom burden in clinical and nonclinical populations. As such, the proposed research will
use a novel dynamic functional connectivity method to determine whether task-based variations in functional
connectivity and behavior differ in children with ADHD and in children without ADHD (categorical approach;
Specific Aim 1), and whether there are relationships among ADHD symptom burden, functional connectivity
dynamics, and behavior in a large sample of children with continuous ADHD-related symptom measures
(dimensional approach; Specific Aim 2). Exploratory Aim 3 will further probe the heterogeneity in ADHD symptom
burden that exists within and across ADHD by using a community detection algorithm to identify subgroupings
of individuals with and without ADHD that exhibit similar symptom profiles. Together, the three aims of the
proposed research will contribute to the development of strategies that allow for the identification of individuals
who may benefit from treatment and intervention for ADHD symptom burden across diagnostic categories.

Public health relevance
PROJECT NARRATIVE Attention-deficit/hyperactivity disorder (ADHD) is a highly prevalent neurodevelopmental disorder that affects over 6.1 million children in the United States and approximately 5-10% of children worldwide. Individuals with and without clinical ADHD diagnoses can experience a wide range of ADHD symptoms; therefore, understanding the neural substrates that underlie the heterogeneous ADHD phenotype will allow for better transdiagnostic identification of individuals who may benefit from treatment for ADHD-related symptoms. Thus, the proposed studies will implement a dynamic functional connectivity approach and assess behavioral variability associated with ADHD symptom burden within and across diagnostic categories to better understand the neurobiology of the ADHD phenotype.